Mechanisms regulating the maturation of prefrontal top-down circuity in control of attentional behavior

Abstract for Alzheimer's-focused administrative supplement for R01MH119523
Cognitive decline is one of frequent challenges accompanying Alzheimer's disease (AD). The goal of this study
is to examine to what extent a PFC cognitive control circuit identified in the ongoing R01 project is vulnerable
to AD risk gene manipulation and also responsible for cognitive control behavior to establish pre-clinical
strategy for ameliorating cognitive deficits in AD.
As a part of our R01 project, we recently demonstrated that PFC top-down frontal-sensory projections from
anterior cingulate area (ACA) to visual cortex (VIS) (ACAvis projection) plays an essential causal role in
cognitive control by linking error monitoring and attention adjustment in mice (Norman et al Neuron 2021).
Further, we found that this circuit is disrupted in a mouse model of Fragile X syndrome, but this circuit deficit
can be targeted to prevent attention deficits (Falk et al Science Advances 2021). Of note, Aβ is over-expressed
in the brain of Fmr1KO mice, suggesting seemingly disparate neurologic diseases (FXS and AD) may share a
common pathology. Consistently, our preliminary study using APP knock-in (KI) mouse, which contains
humanized sequences and mutations in the endogenous mouse APP gene, showed reduced correct
performance selective after error trials, suggesting that AD-risk gene is associated with deficits in post-error
attention adjustment, a key aspect of cognitive control. As functional cortical imaging around the onset of AD
shows accelerated posterior-anterior shift in aging (PASA), we hypothesize that AD-related APP mutations
disrupt top-down frontal-sensory projection and associated network contributing to cognitive control deficit. We
will test this hypothesis by applying the techniques all established by the parent R01.
Aim 1 will examine the impact of AD related APP mutations on frontal-sensory network by studying synaptic
inputs onto ACAvis projection neuron in APP KI mice through patch-clamp recording. Aim2 will study the
recruitment of frontal-sensory projection during cognitive control behavior in APP KI mice by in vivo fiber
photometry calcium imaging. Aim3 aims to ameliorate cognitive control deficits through the optogenetic
modulation of frontal-sensory projection in APP KI mice.
Given that Aβ is over-expressed in Fmr1KO brain, the proposed study using APP KI model fits within the
scope of parent R01 which studies attention deficits in Fmr1KO mice using the same circuit techniques. This
project will be conducted in collaboration with Dr. Joseph Castellano (co-I: Ronald M. Loeb Center for
Alzheimer’s disease at Mt. Sinai) who has an extensive expertise and working knowledge of APP KI mouse
model and AD pathology. Successful completion of the proposed experiments will set a stage for future R01
project with more in depth network analysis combining spike/LFP recordings from frontal and sensory cortical
areas in behaving animals, and also exploration of long-lasting cognitive deficit rescue strategies.

Public health relevance
The goal of this study is to identify the mechanisms of prefrontal circuitry that mediate top-down control of attentional network and behavior by integrating techniques to measure and manipulate neural activities within specific circuits of freely moving animals. This study would provide insight into the new potential circuit-specific diagnosis methods and interventions in brain disorders.